STING induced IFNL2/3 protects human intestinal epithelial cells from rotavirus infection

Project summary
The double-stranded RNA virus rotavirus is one of the leading causes of enteric virus induced deaths
worldwide. Upwards of 200,000 people, mostly children, die due to rotavirus infection each year. While several
rotavirus vaccines have been developed and efficiently protect children in the developed world, they display poor
efficacies in developing countries where they are needed the most; indicating that alternative strategies to
combat rotavirus infection are greatly needed.
Rotaviruses infect the intestinal epithelial cells lining the surface of the gastrointestinal tract. Upon
rotavirus infection these cells upregulate type I and type III interferons to combat rotavirus infection. Recent work
from our lab has shown that type I interferons are dispensable for controlling rotavirus infection. We found that
type III interferons are the key cytokines which restrict rotavirus replication and spread in human intestinal
epithelial cells. Humans express four type III interferons (IFNl1, IFNl2, IFNl3, and IFNl4). How each subtype
of type III interferon is produced following virus infection and whether the different subtypes of type III interferon
have subtype-specific antiviral properties remain mostly unknown.
To unravel how rotaviruses induced type III interferons in human intestinal epithelial cells, we used
genetic depletions and pharmacological inhibitors. We could show that intestinal epithelial cells produce type III
interferons following rotavirus infection through both the RIG-like receptor (RLR) and STING pathways. These
preliminary data report for the first time that rotavirus infection can be sensed by the STING pathway which
normally is responsible for sensing DNA virus infection. In addition, we found that RLRs and STING each lead
to the upregulation of distinct type III interferons: RLR activation upregulated IFNl1 and IFNl2/3 while STING
led to the exclusive upregulation of IFNl2/3. To determine whether IFNl1 and IFNl2/3 were equally important
to control rotavirus infection we genetically depleted them in our human intestinal epithelial cells. We found that
IFNl1 was dispensable for controlling rotavirus infection while IFNl2/3 was critical for controlling rotavirus
infection and spread. In this proposed project we will further investigate how STING is activated following
rotavirus infection and determine how distinct type III interferon subtypes (IFNl1 vs IFNl2/3) can be upregulated
depending on the pattern recognition receptor which is activated. Together these results will give us insight into
tissue specific mechanisms used to combat viral infection and provide novel insight into whether IFNl2/3 could
be implemented as anti-rotaviral therapeutic measure in areas of low vaccine efficacy.

Public health relevance
Narrative Type III interferons (IFNl1, IFNl2 and IFNl3) are key cytokines used by intestinal cells to control rotavirus infection. We have uncovered that not all subtypes of type III interferons display equal antiviral activity against rotavirus: IFNl1 is dispensable for controlling rotavirus infection while IFNl2/3 made downstream of both RIG- like receptors and STING signaling is critical to control rotavirus infection in intestinal cells. Further understanding of the pathways used by intestinal cells to upregulate IFNl2/3 are critical to develop novel pharmacological strategies to combat rotavirus infection.